Metastasis

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Metastasis, organized by Drs. Joan
Massagué, Sean Morrison and Caroline Dive. The conference will be held in Vancouver, British Columbia
Canada from May 7- 10, 2023.
Most cancer deaths are caused by distant metastasis, yet the mechanisms that regulate distant metastasis are
poorly understood. Metastasis is a very inefficient process in which few disseminated cancer cells survive, and
even fewer proliferate, but little is known about why. This conference will address the nature of metastasis
initiating cells as well as their phenotypic plasticity, genetic and epigenetic evolution. Speakers will cover
topics including the characterization of circulating cancer cells and how recent advances in imaging and DNA
analysis are assisting the clinical management of metastasis. Other sessions will cover why cancer cells
sometimes go dormant after metastasis. Additionally, the program will include sessions which will discuss the
metabolic regulation of metastasis and how the metabolic environment influences the survival of cancer cells
during metastasis. Finally, this conference is being paired with the Keystone Symposia conference entitled,
The Resistant Tumor Microenvironment. There will be joint sessions and attendees of both conferences will be
able to interact and network during mealtimes and poster sessions.

Public health relevance
PROJECT NARRATIVE It has recently become clear that the biology of metastasizing cells differs from cancer cells in established primary and metastatic tumors because, during metastasis, the cancer cells experience a range of stresses that kill most metastasizing cells. This means that metastasis actually represents a period of vulnerability for cancer cells. This Keystone Symposia conference is a timely gathering of experts from diverse fields, who all study the various biology of metastasizing cells, to come together for the ultimate goal of reducing the physical, emotional and economic burden of cancer.